A systems approach to decode mitochondrial metabolite transport

Project Summary/Abstract
Mitochondria house the metabolism of all building blocks of life and are central for cellular metabolism,
however, how metabolites translocate across the mitochondrial membrane is poorly understood; and the
impact on neuronal cellular metabolism is yet to be explored. The mitochondrial carrier SLC25 family
represents the largest protein family critical for mitochondrial metabolite transport, in which approximately
20 out of the 53 human SLC25 genes remain of unknown function. Our overarching research program is
to characterize mitochondrial metabolite transport by identifying the endogenous metabolite ligands for
SLC25 transporters. Recently, my laboratory applied mitochondrial metabolomics to discover the role of a
poorly characterized mitochondrial transporter SLC25A39 in glutathione uptake (supported by R00). Here,
building upon this recent progress, we propose to expand the strategy to other SLC25 transporters using
loss-of-function and gain-of-function study in cells. As a distinct and complementary approach, we will
apply sequence and structure analysis towards SLC25 transporter to guide in vitro mitochondrial
metabolite uptake screen with a goal to characterize ligand recognition mechanism. To study mitochondrial
metabolism in neurons, we will adopt iPSC-derived neurons as an in vitro model to profile the impact of
SLC25 transporters loss on mitochondrial and synaptic metabolism. Together, our study of SLC25
transporters would reveal fundamental biology in mitochondrial metabolite transport, an emerging new
frontier in cellular metabolism. Our expertise in cellular metabolism, uniquely in applying state-of-art, high-
resolution mass spec metabolomics to fundamental biochemistry and cell biology, is perfectly suited for
the research direction. The ESI-MIRA program enables launching my research career in cellular
metabolism as well as moving into a new research area in neuronal cell biology. The flexibility in the funding
mechanism allows this ambitious project to systematically decode mitochondrial metabolite transport.

Public health relevance
Project Narrative Mitochondrial metabolism is implicated in human diseases including brain disorders, however, while protein-mediated metabolite translocation directly governs metabolism within this organelle, the process is poorly characterized. By applying our metabolomics-based approach to characterize the largest human mitochondrial transporter SLC25 family in cells, with a focus on neuronal cells, our research promises to discover new molecular mechanisms in mitochondrial metabolite transport, enabling new directions in the pathophysiology underlying brain disorders.